Parkinson’s disease biomarkers in human olfactory cleft mucus

PROJECT SUMMARY
Early diagnosis of Parkinson’s disease (PD) remains a big challenge, as clinicians are still lacking reliable
biomarkers. PD patients are typically diagnosed when they have already developed motor deficits, indicating
significant loss of dopaminergic neurons in the substantia nigra has already occurred. Olfactory impairment is
one of the earliest symptoms of PD, often occurring several years before motor deficits. Lewy bodies, the
histopathological hallmarks of PD, accumulate in the olfactory bulb in early stages of PD. Recent evidence
indicates that aberrant α-synuclein (α-Syn), the main protein component of Lewy bodies, can propagate
transneuronally from the olfactory bulb, further suggesting the critical role of the olfactory system in PD
pathogenesis. However, to date, human olfactory tissue has not been comprehensively examined to identify
molecular biomarkers for PD. The goal of this R21 project is to identify PD biomarkers in human olfactory cleft
mucus. Olfactory sensory neurons are concentrated in the superior turbinate of the nose, projecting axons to
the olfactory bulb in the brain. Our recent proteomics studies using human olfactory cleft mucus, a biofluid
covering the surface of the olfactory mucosa, identified several well-established PD-associated proteins,
including α-Syn, DJ-1, and inflammatory biomarkers. Preliminary studies of a PD patient cohort showed that
the ratio of α-Syn to DJ-1 and levels of certain inflammatory biomarkers are substantially elevated in the
olfactory mucus of PD patients compared to age-matched controls. Preliminary data also showed that the α-
Syn/DJ-1 ratio distinguishes PD patients from control subjects with high sensitivity and specificity, showing
strong biomarker potential. Here we propose to recruit additional patients with early or advanced PD, as well
as age-matched controls. We will use a minimally invasive method established by our research team to collect
olfactory cleft mucus. We will conduct immunoassays to determine levels of α-Syn, DJ-1, and multiple
inflammatory biomarkers. We will test the hypothesis that the ratio of α-Syn to DJ-1 is a reliable biomarker for
PD. Furthermore, we will use machine learning approaches to optimize olfactory biomarkers for PD
progression. This multidisciplinary project brings together investigators with expertise in olfaction, PD
pathology, inflammation, and machine learning. Our research may have a major impact on patient care by
improving early and accurate diagnosis of PD.

Public health relevance
PUBLIC HEALTH RELEVANCE Olfactory impairment is one of the earliest symptoms of Parkinson’s disease, often occurring several years before motor deficits. We will use a minimally invasive method to collect olfactory cleft mucus to identify easily accessible biomarkers of Parkinson’s disease. These biomarkers may support the development of novel tests that can detect the disease earlier, which could have a major impact on patient care.